An Observational Study of IL1 Inhibition for Blocking ACVR1-Induced Flare Activity and Heterotopic Ossification in Fibrodysplasia Ossificans Progressiva

PROJECT SUMMARY
Abnormal responses to inflammatory stimuli can lead to severe inflammation, acute tissue damage, and long-
term scarring or fibrosis. One example is the rare disease fibrodysplasia ossificans progressiva (FOP), a
congenital disease of progressive heterotopic ossification (HO) that leads to severe and irreversible loss of
mobility. Patients with FOP show inflamed swellings (“flares”) that are associated with HO formation. Patients
with FOP have evidence of increased immune system activity, including elevated levels of pro-inflammatory
cytokines like IL1. Preliminary data from four FOP patients treated with anti-IL1 therapy showed a 60–90%
decrease in flare activity. We hypothesize that blockade of IL1 signaling reduces the flare activity and
subsequent new HO formation in patients with FOP. However, before we can perform a larger
interventional study, several key knowledge gaps and tools need to be addressed. We address these
needs via a clinical observational pre-post study on patients with severe FOP who are being recommended for
rescue therapy with anti-IL1 medications. Eleven subjects, aged 6–18 years old with at least six flares/year (3
times higher than the reported average flare rate) will be enrolled when their primary medical team recommends
initiating anti-IL1 therapy. Subjects will be monitored remotely to obtain pre-treatment flare rates and patient
reported outcome assessments. Once anti-IL1 therapy is initiated, subjects will begin their post-treatment
observational phase and have the first onsite visit for detailed assessments. Low-dose whole-body CT (WBCT)
imaging, bloodwork, patient-reported outcomes, pain, and flare activity will be assessed during the subsequent
year. Primary assessments: Determine if patients with FOP have decreased flare activity while on anti-
IL1 therapy. We will use flare diaries and pain scale assessments to systematically determine if flare frequency
and pain improve with anti-IL1 therapy. Aim 2: Secondary assessments: Determine the amount of new HO
formation in FOP patients treated with anti-IL1 therapy. We will develop a “ground truth” HO segmentation
that will serve as a basis for developing an automated artificial-intelligence analyses system. We will also
quantitate the new HO bone formation that develops in patients with FOP who are treated with anti-IL1 therapy.
Aim 3: Exploratory assessments: Determine if inflammatory cytokine measurements can be used as
biomarkers for monitoring flare activity and inflammation in FOP patients treated with anti-IL-1 therapy.
No effective biomarkers are available for FOP disease activity. We will determine if a commercial serum cytokine
panel and thermal imaging are useful tools for assessing flare activity. These studies address urgent needs.
No therapeutic options are available for FOP patients, particularly in children where intervention would have the
greatest clinical benefit. The proposed studies provide critical clinical information potentially relevant to the
immediate care of FOP patients and will generate key tools, such as methods for quantitative HO
formation from CT scans, that will be useful for a future U01-level study and patient care.
1

Public health relevance
PROJECT NARRATIVE This project will contribute to improved public health by helping understand if treating immune overactivity can decrease abnormal bone formation in patients with FOP. The new knowledge will validate important tools and approaches for clinical studies in small cohorts of patients, and also provide critical preliminary data for designing larger studies that may be beneficial for patients with common causes of abnormal bone formation.